Administrative Core

The goal of the ETUDES Center is to develop and test effective and sustainable methods of identifying and
intervening with youth at risk for suicidal behavior in pediatric primary care, with a special emphasis on finding
effective and acceptable approaches for Black youth and their families. The Administrative Core (AC) supports
these goals by convening a diverse, interdisciplinary team of faculty, collaborating with patient, caregiver,
provider, and policy leader stakeholders in the content, design, implementation, and interpretation of Center-
related studies, and appointing a Data Safety Monitoring Board (DSMB) and Scientific Advisory Board (DSMB)
to help evaluate Center progress. The AC is led by an Executive Committee (EC) consisting of key Center faculty,
family advocates, and clinical leadership of the practice networks where the Center activities will take place. A
critical component of the AC and Center’s mission is the training and support of the next generation of Early
Career Scientists (ECSs) focused on intervention research and implementation science in adolescent suicide
prevention. The AC will achieve the following Specific Aims:(1).Set scientific priorities, provide oversight of
projects, resource allocation, and ensure human subjects’ protection. The EC meets monthly to provide oversight
over Center projects and resource allocation. Scientific priorities are developed in collaboration with patient,
family, and clinical Stakeholders, and the SAB. Human Subjects’ protection is assured via training and
standardization of IRB protocols and twice-yearly review by an external DSMB.; (2).Collaborate with
stakeholders and practices in the development, implementation, and interpretation of Center studies. AC Core
faculty will collaborate with four stakeholder groups of patients, caregivers of patients, clinicians, and policy
makers. These groups will review all scientific activities and provide input about scientific priorities for the Center.
Stakeholders also hold leadership positions on the EC; (3).Fund pilot studies and innovation contests: The
Center will solicit applications for pilot funds from ECSs and host 3 innovation contests, which bring together
investigators from the Center and primary care clinicians, to facilitate collaboration and innovative solutions;
(4).Support and mentor ECSs. This application features 10 ECSs, of whom 4 are members of an under-
represented minority group, with several either leading or co-leading one of the Center projects. Each ECS has
one or more senior faculty mentors in the Center and will have a personalized mentorship and career
development plan; (5).Serve as a national resource for suicide research through collaboration and consultation,
mentorship of ECSs who are not at one of the Center sites, and through sharing our products, procedures, and
data; (6). Train pediatricians through the Pediatric Education Program (PEP), a year-long training program in
mental health skills for practicing pediatricians. At least one pediatrician per participating practice will receive
PEP and we will evaluate its impact on knowledge, attitudes, and practices.; and (7). Communicate findings
through publications and presentations, making procedures, products, and data publicly available on our website.